2022 Intrinsically Disordered Proteins Gordon Research Conferences and Gordon Research Seminar

Project Summary/Abstract
The 2022 Gordon Research Conference on Intrinsically Disordered Proteins “The Functional Role of Disorder
in Biological Systems”, to be held June 26-July 1, 2022, in Les Diablerets, Switzerland, will address the
relationship between biological functions of intrinsically disordered proteins and their roles in human diseases.
Disordered proteins have important functional roles in cells, as well as being implicated as key players in a
broad range of devastating human diseases, including neurodegenerative disorders, cancers and
cardiomyopathies. Estimates of the relative fraction of human proteins that are entirely disordered or contain
large disordered regions are between 40-50%. Despite their abundance and their critical roles in both normal
function as well as in disease, our understanding of the functional mechanisms of disordered proteins is
relatively poor. This underscores the importance of basic research aimed at this class of protein whose
constituents do not adhere to the `structure/function' paradigm that has shaped our understanding of globular
proteins, including our ability to target them with therapeutics. The topics presented at the 2022 IDP GRC will
address molecular mechanisms in disordered proteins with a diverse range of native functions, including cell
signaling, biomaterials, plants and circadian clocks. Additional talks will engage with mechanisms of
disordered proteins relevant to disease. Moreover, there will be a number of talks addressing the emerging
phenomenon of IDP-mediated phase separation, an area which links studies of function and dysfunction of
disordered proteins.
Key scientific objectives for the conference are as follows:
Objective 1. To address how the basic physicochemical properties of IDPs relate to their
unique functional mechanisms;
Objective 2. To discuss dysregulation of IDPs in human diseases and how they may be
targeted for therapeutic intervention;
Objective 3. To address the role of disordered proteins in liquid phase separation that underlies
cellular biomolecular condensates or membrane-less organelles
We have also identified the following key logistical objective for the conference:
Objective 4. To promote diversity and inclusiveness in the intrinsically disordered protein
research community through funding to underrepresented groups.

Public health relevance
Project Narrative Intrinsically disordered proteins play critical roles in many cellular functions, as well as many diseases including cancer, neurodegenerative disorders and cardiomyopathies. Research presented at the 2022 Intrinsically Disordered Proteins (IDPs) Gordon Research Conference (GRC) will emphasize molecular mechanisms of intrinsically disordered protein function, as well as understanding how dysregulation of disordered proteins leads to disease. Because of the abundance of disordered proteins implicated in causal roles in diverse human diseases, the research discussed is of significant relevance to human health.